Imaging Protein Synthesis on the Ribosome using Single-Molecule FRET

PROJECT ABSTRACT:
The mechanism of protein synthesis and its regulation in the cell determines the diversity and capacity of the
proteome. The central integration point for this regulatory control is the ribosome: a two-subunit, megadalton
RNA-protein assembly. Highlighting the exquisite sensitivity of translation and the ribosome to regulation, the
majority of known antibiotics either dysregulate or block ribosome function. Correspondingly, delineation of the
protein synthesis mechanism in molecular detail has the potential to inform on paradigms of gene expression
control and on how to combat the global health threat of emerging and drug resistant pathogens. As the loss of
translation control is a hallmark of cancer, a deeper understanding of the protein synthesis mechanism also
holds the promise of targeted therapeutic strategies for human disease treatments that are currently lacking.
Investigations into structure-function relationships governing the translation mechanism have been principally
conducted in bacteria using traditional ensemble methods. Such studies have revealed that the phase of
translation in which protein is synthesized from messenger RNA (mRNA), termed elongation, is the most time
intensive and commonly drug-targeted. They have also discerned that elongation entails the ribosome transiently
interacting with specific cellular components through an ordered series of events, where the decoding of each
mRNA codon is accompanied by large-scale conformational changes within the ribosome and interacting factors,
and between the ribosome and its mRNA and transfer RNA (tRNA) substrates. The need for large amounts of
homogenous material has thwarted analogous investigations of the human translation mechanism. Hence,
conserved and divergent features of the translation mechanism between single-cell organisms and mammals
that determine the molecular basis of antibiotic specificity have remained largely obscure. Here, we seek to
delineate common and distinct features of bacterial and human protein synthesis — and the translation
mechanisms in healthy and cancerous human cells — to: 1] improve the efficacies of existing antibiotics; 2]
develop new strategies for antibiotic interventions; and 3] explore the possibility of therapies targeting unchecked
proliferative cell growth and metastatic spread. We will do so by establishing quantitative, structural and kinetic
frameworks for the elemental steps of elongation in bacteria and humans using an integrated battery of
biophysical methods, including single-molecule fluorescence imaging and state-of-the-art cryo-electron
microscopy. Our collaborative investigations will delineate the order and timing of conformational events
underpinning fidelity in bacterial and human elongation cycles and the structural and mechanistic distinctions
that determine the efficacies of clinically relevant antibiotics targeting these processes. These insights will shed
light on how translation control is achieved, reveal atomic-resolution descriptions drug action on bacterial and
human ribosomes and inform opportunities for new interventions aimed at improving the efficacy and potency of
clinical treatments for infectious pathogens and human disease.

Public health relevance
PROJECT NARRATIVE: Protein synthesis regulation is a central point of gene expression control and targeting this process with small molecules has been a proven line of defense for the treatment of infectious disease for nearly a century. Unfortunately, incomplete knowledge of the protein synthesis mechanism has hampered progress towards delineating the molecular basis of regulation – and thus the design of novel translation-targeting agents – while the threat of antibiotic resistance is increasing. Through an integrated battery of quantitative biophysical and structural investigations, we seek to define complete kinetic mechanisms of bacterial and human protein synthesis reactions to gain critical new insights into the molecular origins of antibiotic action and specificity that can be used to inform clinical strategies for combating infectious pathogens and for treating human disease.